Cannabis' Impact on Alcohol Consumption: Integrating Laboratory and Ecological Momentary Assessment Methods

PROJECT SUMMARY/ABSTRACT
Cannabis is the most common psychoactive drug co-used with alcohol among individuals with alcohol use
disorder (AUD). The current proposal advances our team’s research on the impact of cannabis use (CU) and
cannabis-alcohol co-use on alcohol-related outcomes. Findings from clinical studies indicate that CU is
strongly linked with alcohol use, although evidence regarding whether cannabis reduces or increases drinking
is mixed. Our research has demonstrated that Δ-9-tetrahydrocannabinol (THC) acutely reduces relative alcohol
value and consumption in heavy cannabis and alcohol co-users under controlled laboratory conditions.
Evidence from animal models on cannabidiol (CBD) suggests CBD may also reduce alcohol craving and
consumption. An important gap in current clinical research is lack of human laboratory studies that examine
alcohol consumption in relation to cannabis varying in cannabinoid composition (THC and CBD). Moreover,
aside from data on pharmacodynamic interactions between cannabis and alcohol, no human laboratory studies
have examined the combined effects of alcohol and cannabis (i.e., marijuana; simultaneous use-SAM) on
alcohol consumption. Finally, no previous study has evaluated the impact of cannabis on alcohol use within the
same individual under both controlled laboratory conditions and in the natural environment. This project will
provide the most comprehensive tests of the impact of cannabis on alcohol outcomes using a multi-method
design: (1) controlled laboratory administration of THC versus CBD smoked alone versus simultaneously with
alcohol and (2) ecological momentary assessment (EMA) of event-level contextual factors that can help
elucidate the associations between CU and alcohol-related outcomes in daily life contexts. The laboratory
phase will employ a 3 (within-subjects cannabinoid dose: 12% THC/<1% CBD, 12% CBD/<1%THC, placebo) X
2 (between-subjects: cannabis + an alcohol-priming dose versus cannabis + alcohol placebo) mixed factorial
design to examine these effects on subsequent drinking in 200 nontreatment-seeking heavy episodic alcohol
drinkers who use cannabis weekly (Aim 1). Data from this laboratory phase will be integrated with smartphone-
based data on CU patterns (amount, THC/CBD ratio, potency, mode), context (location, social), alcohol
craving, consumption, and consequences collected from the same individuals over a 4-week EMA period.
Integration of laboratory and EMA data enables examining the unique influences of laboratory-based cannabis
state-dependent alcohol response variables and field-based CU and contextual factors on alcohol craving,
consumption, and consequences (Aim 2). Cannabis (medical and recreational) and SAM motives and AUD
severity will be explored as potential moderators of the associations between CU and alcohol behaviors in the
natural environment (Aim 3). This research is well-aligned with the objectives of the Collaborative Research on
Addiction at NIH and has important implications for cannabis regulatory science and AUD treatment by
addressing the relative impact of specific cannabinoids as well as contextual risk in cannabis-alcohol co-use.

Public health relevance
PROJECT NARRATIVE Cannabis and alcohol co-use is a major public health concern, but little is known whether specific cannabinoids, alone or in combination with initial drinking, increase or decrease alcohol risk in humans. The project will use a combination of controlled laboratory methods and mobile technology to examine the immediate influences of Δ-9-tetrahydrocannabinol (THC) and cannabidiol (CBD) on alcohol consumption in the laboratory and in real life contexts in a person’s daily life. The project will provide information critical to the development of policy, prevention, and treatment efforts to reduce the significant health and economic impact of alcohol use disorders.